MODELING NEURONAL MECHANISMS OF VISUAL SPACE PERCEPTION

Single neurons in the medial superior temporal area (MST) of Rhesus monkeys have been found to show selective responses to visual stimuli simulating the motion seen as a result of observer self movement. In the monkey neurophysiology laboratory we are continuing studies of the responses of these neurons to visual stimuli. In a collaboration with researchers at College de France (co-sponsored by a grant from the Human Frontiers Scientific Program, 1996-1999, P1 Werner Graf) we are investigating the response properties of neurons in a variety of cortical areas. These neurons are being tested to identify and characterize interactions between visual cues about self-movement with non-visual cues about self-movement. Our work focuses on neurons in the MST, where we have successfully recorded such responses (see Figure). Work in France focuses on similar experiments in the ventral intraparietal area (VIP).